Program to Increase Diversity in Faculty Engaged in Behavioral and Sleep Medicine (PRIDE)

Project Summary
The overarching goal of the NYU Behavioral Medicine and Sleep Disorders (BSM) Institute is to continue
building capacity to address a critical deficiency in the academic workforce. This will be achieved by
providing congruent mentored learning experience to an additional cadre of URM faculty pursuing careers in
cardiovascular (CV) risk reduction via implementation of translational behavioral models. The Institute
commences with a 2-week didactic program (Summer I), followed by on-going consultation with a Mentoring
Team, monthly webinars, a mid-year meeting to present work in progress and scientific findings, and ending
with a 1-week follow-up program (Summer II). The initial 2-week didactic sessions focus on methodology,
biostatistics, ethical conduct in research, behavioral medicine and sleep disorders topics, and intensive
grant writing workshops. The 1-week follow-up program provides URM mentees with opportunities for one-
on-one interactions with NHLBI staff; participation in NIH Mock Study Section; and peer proposal critiques.
In partnership with distinguished investigators at New York University and NHLBI staff, we will implement
and evaluate the BSM curriculum throughout the 5-year period. Together with the Coordination Core (CC),
we will apply our established evaluation protocol to assess effectiveness of the Institute and to track
mentees’ progress for 5 years post completion. Outcomes include: 1) number of professional presentations
and peer-reviewed publications; 2) leadership positions; 3) career awards; and 4) federal and non-federal
grants. Mentees’ characteristics predicting academic success will be measured pre and post enrollment.
The specific aims are: 1) to select qualified junior URM faculty with potential to contribute to current
knowledge of behavioral and biomedical models used to reduce risk of CV-related diseases; 2) to increase
mentees’ self-efficacy to pursue a BSM career, achieved via active coaching to realize their Individual
Development Plan and acquisition of expertise in applying translational behavioral tools; 3) to work with the
CC to administer the Small Research Project; 4) to provide congruent mentorship to mentees, enabling their
transition into independent investigators; 5) to provide mentees with intensive individualized training and
guidance in grant writing using new NIH review criteria; and 6) to evaluate effectiveness of the Institute
ensuring milestones are achieved in timely manner. The Co-Directors will work directly with the CC to
execute BSM’s programmatic activities, implement program evaluation plan, monitor mentees’ progress
during enrollment, and tracking mentees’ academic achievements. Successful completion of this renewed
Institute will establish and maintain a network of 48 well-trained URM faculty, applying evidence-based
methods to improve health equity in disparity communities.

Public health relevance
Project Narrative The goal of the NYU Behavioral Medicine and Sleep Disorders Institute is to continue building capacity to increase diversity in the academic workforce. This will be achieved by providing congruent mentored learning experience to an additional cadre of 48 URM faculty pursuing careers aiming at cardiovascular risk reduction through implementation of translational behavioral models. Trained URM faculty will be empowered to develop independent careers in behavioral medicine and sleep disorders research, applying proven methods to improve health equity in disparity communities.